IMproving Pediatric Access to Clinical Trials in Vermont (IMPACT VT)

PROJECT SUMMARY/ABSTRACT
University of Vermont Medical Center (UVMMC) serves a highly rural region with numerous underserved
areas. Children in the region receive primary care in both community-based and UVMMC-affiliated practices,
and specialty care at University of Vermont Children's Hospital. Primary care and subspecialty providers have
clinical and research expertise in the Environmental Influences on Child Health Outcomes (ECHO) interest
areas and established collaborations with the clinical site to facilitate clinical trial access for rural children.
Collaboration with the Northern New England Clinical Translational Research Network (NNE-CTR), families,
and community groups aids rural outreach. In collaboration with other ECHO IDeA States Pediatric Clinical
Trials Network (ISPCTN) sites, the DCOC, and the NIH, the UVM site (UVM) works to improve clinical trials
access, develop and implement clinical trials pertinent to rural and underserved children, and train pediatric
investigators committed to clinical trials research for this population. A significant discrepancy exists between
the burden of disease in the pediatric population and opportunities to participate in clinical research, and rural,
underserved, and minority children are particularly underrepresented. UVM's objective is to continue to
collaborate with other ISPCTN sites in the development and conduct of multicenter clinical trials with a focus
on access for children in rural and underserved communities and to leverage the site's prior successes as an
ISPCTN site to further expand the pediatric research capacity at UVM. UVM is committed to remaining an
integral part of the ISPCTN, and will advance the goals of the network through the following specific aims: 1.
UVM will collaborate in the development and conduct of ECHO ISPCTN clinical trials and provide
leadership in the clinical trial development pipeline. UVM will build on the site's previous work, expand the
site team, support new investigators, and share resources to develop and conduct clinical trials. 2. Through
training, mentoring, and participation in ECHO ISPCTN trials, UVM will expand local expertise in
pediatric clinical trial conduct and collaborate with other sites to share this expertise. UVM will expand
their Pediatric Clinical Trials Learning Collaborative program that provides clinical research training and
American Board of Pediatrics Maintenance of Certification (MOC) credit for QI activities, to improve clinical
trials access and monitor regulatory requirement adherence. UVM will leverage resources including the DCOC,
ISPCTN site collaborations, IRB, NNE-CTR, and outside research network programs. 3. UVM will enhance
access to pediatric clinical trials for rural and underserved children, with the goal of improving the
health of all children. The UVM outreach program will leverage existing relationships and collaborations (e.g.
rural networks of health providers, NNE-CTR, and community stakeholders) to both offer participation in and
collaborate in the development of pediatric clinical trials. UVM will encourage participation through MOC
incentives and by reducing barriers to participation.

Public health relevance
NARRATIVE Despite being a large segment of the population, rural, minority, and underserved children are traditionally underrepresented in clinical trials, often due to decreased access. Failure to represent these children in pediatric studies overlooks the needs of an important segment of the population, limits the scientific evidence base, and leads to unequal distribution of the opportunity to benefit from medicine and research. Our program, IMproving Pediatric Access to Clinical Trials in Vermont (IMPACT VT) will continue to collaborate as an ECHO IDeA States Pediatric Clinical Trials Network Site to improve clinical trials access, develop and implement clinical trials pertinent to our populations, train a pipeline of pediatric investigators committed to clinical trials research for rural and underserved children, and in the long-term decrease disparities with the goal of improving health for all children.